Mechanistic Studies of α-Synuclein Prion-Like Transmission in Disease Models

Project Summary/Abstract: α-synuclein (αS) is an abundantly expressed neuronal protein which forms
pathological inclusions in a spectrum of neurodegenerative diseases. Although αS inclusions are a commonality
in Parkinson’s disease (PD), Lewy body Dementias (DLB), and Multiple System Atrophy (MSA), the cellular and
regional distribution of pathological inclusions varies widely between diseases. Importantly, the progression of
these diseases corresponds with the spread of αS pathology through the CNS. The progression of αS pathology
requires the aggregation and propagation of αS inclusions, although the origins and mechanisms of this process
are not well understood. Biochemical and ultrastructural studies of aggregates from human disease brains and
prion-type αS propagation models have revealed distinct properties of αS in various disease contexts, lending
to the hypothesis of disease strains. In this strain hypothesis, it is thought that the cell types and regions in which
αS inclusions form imbue conformational distinctions to aggregates, leading to distinct pathological courses.
Post-translational modifications (PTMs) can imbue distinct biochemical characteristics and represent a
mechanism for generating disease strains. Of these PTMs, extensive cleavage of the acidic, carboxy (C)-terminal
residues is a common modification to αS found in pathological inclusions and one that leads to increased
aggregation of αS in vitro. In mouse models seeded with human disease brain extracts, the abundance of αS
pathology and specific C-terminally cleaved αS rich pathology reveals differences in disease strains. Our lab has
generated a large panel of αS antibodies, including those to C-terminally cleaved αS, which show the
heterogeneous nature of αS pathology in both LBD and MSA. Most notably, we have found populations of
neuronal pathology in the pons of MSA brains which is distinct from the predominant oligodendrocytic pathology
that defines MSA. αS in the CNS is primarily expressed in neurons, and therefore newfound neuronal pathology
represents a point of origin for the broader oligodendrocytic pathology in MSA. The connection between affected
cell types, patterns of C-terminal cleavage, and the potency of tissue-derived seeds is not understood. For this
reason, the present study will leverage the seeding properties of human brain-derived and recombinant αS
aggregates to study seeding dynamics in mouse lines that express human αS and which have a known disease
phenotype. Aim 1 will compare seeding using brain extracts from the pons or cerebellum from MSA cases,
distinguishing their seeding activity immunohistochemically with a panel of novel, truncation-specific antibodies.
Aim 2 will investigate the differential seeding properties of synthetic αS fibrils comprised of specific disease-
relevant C-terminally truncated forms of αS compared to that of full-length αS. These studies will provide insight
into the pathogenesis of αS related diseases, differentiating regional pathology, and exploring C-terminal
truncation of αS as a disease mechanism.

Public health relevance
Project Narrative Parkinson’s disease, Lewy Body Dementia, and multiple system atrophy (MSA) are different neurological disorders that involve the aberrant clumping of the protein alpha-synuclein. The events that cause the aggregation of alpha-synuclein in the brain or why it produces different diseases are not well understood, although they seem to occur differently in different brain regions and are associated with cleavage of alpha- synuclein. During this fellowship, I will explore the pathology of different brain regions and model the spread of alpha-synuclein disease with human brain tissue and cleaved forms of alpha-synuclein using the highly specific tools we have developed, allowing us to understand events that lead to these disorders.